Community Engagement in Workplace & Environmental Health Research

Community Engagement in Workplace & Environmental Health Research:
A Workshop for Young Professionals
Abstract
This conference will be a 1½ day workshop to identify ways to effectively involve workers,
worker advocates and community representatives in exploratory research projects to improve
environmental conditions in the workplace and community. The workshop will kick off activities
for the 20th anniversary of the Occupational Health Internship Program (OHIP) culminating in: 1)
presentations by interns at the 2023 American Public Health Association (APHA) conference in
Atlanta and 2) an OHIP alumni panel webinar to highlight the importance of integrating work into
environmental and public health interventions and of recruiting a diverse group of young people
into the field. The workshop, and OHIP overall, are consistent with several of NIEHS’s strategic
goals, including training the next generation of EHS professionals, promoting greater workforce
diversity, confronting environmental health disparities, and advancing collaborative partnerships
to translate research to action (NIEHS Strategic Plan 2018-2023).
The workshop will be hosted by the UCLA Labor Occupational Safety and Health Program
(LOSH), an awardee of the NIEHS Worker Training Program (WTP), and will be held in
conjunction with the OHIP national orientation scheduled for June 2023 in Los Angeles.
Participants will include a diverse group of 16-20 interns who will be based in the community at
sites throughout the country in summer 2023 as well as an additional 20-25 OHIP alumni,
community, environmental justice and worker advocates, university researchers, and
government agency representatives.
Upon completing the workshop, participants will be able to:
1. Explain the value of involving workers and community members in environmental and
occupational health programs to protect underrepresented groups.
2. Apply effective community-based research and education approaches to efforts to
control workplace/environmental exposures among diverse populations.
3. Describe the links between workplace and community environmental exposures.
4. Identify opportunities to further develop occupational and environmental health research
skills and pursue career options after the internship program.

Public health relevance
Project Narrative UCLA-LOSH proposes a 1½ day workshop on “Community Engagement in Workplace & Environmental Health Research” in June 2023. This conference will bring together a diverse group of interns, community, labor and environmental justice advocates, university researchers and government agency representatives to address public health issues.